The intestinal microbiome contribution to colon cancer and senescence

Project Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-045.
Colorectal cancer (CRC) is correlated with age (unmodifiable risk factor) and has been linked to the gut
microbiome (potentially modifiable risk factor). Our preliminary data suggest that the microbiome may drive
age-related changes in the colon such as senescence. We therefore hypothesize that age-related changes in
the intestinal microbiome functionally alter colon homeostasis and its microenvironment, thereby promoting the
formation of neoplastic lesions. We further hypothesize that increased cellular senescence in the colon stroma
functionally connects the microbiome with tumor formation. In Aim 1, we will colonize tumor-prone gnotobiotic
Fabp1-Cre+ mT/mG+ Pik3ca*+ ApcMin/+ mice with microbiomes from young and old human donors to
determine whether “geriatric” microbiomes promote the formation of colonic tumors. In Aim 2, we will colonize
germ-free wild-type mice with microbiomes from young and old human donors to determine whether “geriatric”
microbiomes induce cellular senescence in the colonic stroma. Our studies will lay the foundations to develop
microbiome-based strategies (concretely manifesting as dietary modifications or transplant-based
interventions) for colorectal cancer prevention and improvement of health span.

Public health relevance
Project Narrative The gut microbiome is a modifiable risk factor in the development of colorectal cancer, a highly prevalent cancer which is strongly correlated with age. However, it is unknown whether age-associated changes in the microbiome impart risk of developing colorectal cancer. Here we propose to address this critical knowledge gap by transplanting human fecal microbiome samples from young and old human beings into gnotobiotic mice and quantifying the development of consequent age-associated precancerous changes and tumor burdens.